Multi-Scale Multi-Modality High Resolution Mapping of the Adult Human Lung

Project Summary/Abstract
Data Analysis Core
Synthesis of the Multimodality High Resolution 3-D Atlas of Human Lung
The Data Analysis Core (DAC) is responsible for all aspects of data and metadata management, processing,
analysis, mapping, and sharing for this Tissue Mapping Center (TMC) and of the Organ Specific Project focused
on the adult healthy human lung (i.e., Lung Specific Project or LSP). We will take a long view of an Atlas, as a
collection of 2D and 3D maps containing images, tabular data, facts about multiple locations at varying resolution
and indexes of named objects keyed to coordinates of a locational grid analogous to latitude and longitude, to
cartographically present the whole range of salient features of the human Lung. The DAC will support the TMC
in these activities by providing a protected environment for data storage and computation, and by developing
robust reproducible, reusable, and scalable computational workflows thus enabling the integration of data types
into 3D maps for the purpose of creating an interactive and queryable biomolecular human atlas. The DAC is an
essential part of the TMC in its objectives to produce and deliver to the HIVE extensive sets of high-resolution
spatial mappings of molecular entities, using open formats, and within the context of the cellular and extracellular
organization of the Lung. The DAC will accomplish its role through the following Specific Aims: 1) Ingest and
process TMC datasets, 2) Analyze datasets in support of generating multiscale, multiparameter lung tissue
maps, tabular data, and annotations, 3) Construct 2D and 3D lung tissue maps with integrated datasets and 4)
Coordinate planning and atlas production with the HuBMAP Consortium.